Cardiovascular Consequences of Duchenne and Becker Muscular Dystrophinopathies

ABSTRACT/PROJECT SUMMARY
Duchenne and Becker muscular dystrophinopathies (DMD/BMD) have a mutation in the dystrophin gene that,
together, represent over 80% of all cases of muscular dystrophy. Historically, respiratory failure was the major
cause of morbidity and mortality but recent treatment advances have changed the prognosis, with dilated
cardiomyopathy and the resulting heart failure now being the leading cause of death. Currently, there is no
consensus on predictors of cardiac disease trajectory, when to start treatment with cardiac medications, or the
most appropriate outcome measures to evaluate the impact of therapies on the heart in patients with DMD and
BMD. The long-term goal is to reduce the incidence and delay the progression of dilated cardiomyopathy/heart
failure in children with DMD and BMD. The objective of this study is to determine the effects of DMD and BMD
on peripheral vascular function and pulsatile load on the left ventricle (LV), and to determine if these variables
can predict cardiac function. The central hypothesis is that both DMD and BMD patients will exhibit detrimental
changes in their peripheral vascular health and pulsatile load on the LV which will relate to their cardiac function.
This hypothesis is based on novel preliminary data showing an attenuation in peripheral vascular function and
augmented central pressures and wave reflections, suggestive of increased pulsatile load, in both DMD and
BMD patients. The central hypothesis will be tested by pursuing three specific aims: 1) Determine the effects of
DMD and BMD on peripheral vascular function; 2) Determine the effects of DMD and BMD on pulsatile load on
the LV; and 3) Determine if peripheral vascular function and pulsatile load on the LV can help predict cardiac
function in patients with DMD and BMD. Under the first aim peripheral vascular function will be assessed using
both a cross-sectional (baseline) and longitudinal design (12 & 24 months) in cohorts of DMD and BMD patients
and typically-developing children. For the second aim, pulsatile load on the LV will be evaluated by assessing
reflection magnitude, forward wave amplitude, aortic characteristic impedance, and arterial stiffness in the same
design and participants as study aim 1. Finally, the third aim will use measures of peripheral vascular function
and pulsatile load to evaluate predictors of cardiac function measured by echocardiography. The research
proposed in this application is innovative because it represents the initial attempts at determining peripheral
vascular function and pulsatile load on the LV in DMD and BMD patients which is the logical next step to previous
animal studies. Additionally, the study uses novel, state-of-the-art non-invasive methodology that has the
potential to be integrated into regular clinical practice to better diagnose and possibly predict cardiomyopathy
development throughout DMD and BMD disease progression. The proposed research is significant because it
will inform future interventional studies, including clinical trials that will ultimately alter the trajectory of care for
the young patients struggling with DMD and BMD-related cardiomyopathy.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it is focused on reducing the incidence and delaying the progression of dilated cardiomyopathy and heart failure in children with Duchenne and Becker Muscular Dystrophy (DMD and BMD). Demonstrating declines in peripheral vascular function, increased pulsatile load on the left ventricle, and determining their predictive capabilities of overall cardiac function will inform future interventional studies, including clinical trials that will alter the trajectory of care for these young patients struggling with DMD/BMD-related cardiomyopathy. Thus, the proposed research is relevant to the part of the NIH's mission that pertains to lengthening life and reducing illness and disability.